Gfi1-mediated inhibition of the cytostatic effect of TGFβ in the hematopoietic system

Project Summary Growth factor independence 1 (Gfi1) is a zinc-finger transcriptional repressor that plays a critical role in hematopoiesis. When aberrantly activated, Gfi1 functions as a dominant oncoprotein that collaborates with c- Myc and other oncoproteins in lymphomagenesis. TGFβ is a secreted cytokine that inhibits cell proliferation and acts as a tumor suppressor in the hematopoietic system. TGFβ induces the expression of CDK inhibitors p21Cip1, p15INK4B, p27Kip1 and p57Kip2, and this effect is mediated at least in part through rapid downregulation of c-Myc, which releases Miz-1 from the Myc/Miz-1 complex to activate Miz-1 target genes, including the different CDK inhibitors. We previously showed that Gfi1 forms a Gfi1/Miz-1/c-Myc ternary complex through interacting with Miz-1 and act in collaboration with c-Myc to repress p15INK4B, p21Cip1 and p27Kip1. In preliminary studies, we demonstrate that Gfi1 inhibits the cytostatic effect of TGFβ and stabilizes c-Myc protein. Notably, Gfi1 also upregulates c-Myc mRNA level. As Gfi1 is a transcriptional repressor, it is less likely that Gfi1 directly activates c-Myc transcription. Our preliminary data identify Kruppel-like factor 6 (Klf6), a tumor suppressor and important regulator of hematopoiesis, as a likely novel Gfi1 target gene. Interestingly, Klf6 has been shown to suppress the expression of c-Myc. Conversely, TGFβ inhibits the expression of Gfi1 and abolishes Gfi1-mediated upregulation of c-Myc in hematopoietic cells. In this proposal, we will examine how Gfi1 functionally interacts with TGFβ and c-Myc to regulate cell proliferation and oncogenic transformation in hematopoietic cells. In aim 1, we will further evaluate the role of Gfi1 in the regulation of cellular response to TGFβ. We will examine whether Gfi1 overexpression or deficiency has an effect on the cytostatic effect of TGFβ in mouse Lin- bone marrow (BM) cells and whether interaction with Miz-1 is required for Gfi1 to counteract the cytostatic activity of TGFβ. We will further examine whether homozygous and heterozygous deletions of Gfi1 affect leukemogenesis arising from loss of TGFβ signaling. In aim 2, we will investigate whether Gfi1 stabilizes c-Myc protein through interacting with Miz-1 and/or competing with c-Myc for a common E3 ubiquitin ligase. We will also address how TGFβ abolishes c-Myc upregulation by Gfi1, and further assess the role of Klf6 in Gfi1- mediated upregulation of c-Myc mRNA level. In aim 3, we will determine the mechanism of Gfi1 downregulation by TGFβ. Specifically, we will address whether TGFβ-activated Smad proteins directly bind to Gfi1 to repress its expression. The proposed research will provide critical insights into the molecular mechanism by which aberrant activation of Gfi1 leads to hematopoietic malignancies and the mechanism whereby TGFβ acts as a tumor suppressor in the hematopoietic system.

Public health relevance
Project Narrative Gfi1 is a nuclear protein that regulates gene expression and is a key regulator of blood cell development, but when abnormally activated, may cause lymphoma, a type of cancer of lymphatic tissue. In this project, we will investigate how Gfi1 acts to inhibit the anti-growth activity of TGFβ, a secreted factor that suppresses tumor development in the body. The proposed studies will advance our understanding of how abnormal activation of Gfi1 leads to lymphoma.